IL-1Beta-Induced Retinal Iron Accumulation in Age-Related Macular Degeneration

PROJECT SUMMARY
Age-related macular degeneration (AMD) is the most common cause of irreversible blindness in the United
States. AMD is characterized by the death of photoreceptors and their supporting cells, the retinal pigment
epithelium (RPE). The Dunaief lab has previously demonstrated that iron accumulates in the photoreceptors
and RPE of AMD patients compared to age-matched controls. Subsequent in vitro and in vivo work
demonstrated that iron accumulation is sufficient for retinal degeneration. Furthermore, iron chelation therapy
is protective against retinal degeneration secondary to a diverse array of toxins and genetic mutations
associated with AMD. However, the mechanism of iron accumulation in AMD is not known. In this proposal, we
utilize magnetic cell sorting technology paired with molecular biology techniques in human and mouse retinal
tissue to test our hypothesis: IL-1β triggers retinal iron accumulation in photoreceptors and RPE, exacerbating
AMD.
In Aim 1, we will isolate cell fractions from AMD and normal retinas to determine which cell-types produce IL-
1β and which cell-types express the receptor proteins necessary for IL-1β signal transduction. We will also
measure mRNA and protein levels of iron transporters in each cell fraction to identify which transporters
contribute to retinal iron overload in the photoreceptors and RPE. In Aim 2, we will use cell sorting to isolate
retinal cell fractions from a mouse model of chronic neuroinflammation. We hypothesize that IL-1β and IL-1β
receptor, IL-1R1, are necessary for iron accumulation and iron transcriptome changes secondary to a chronic
inflammatory stimulus. We also hypothesize that chronic administration of IL-1β, delivered to retina using an
adeno-associated virus, will be sufficient for changes in the retinal iron transcriptome and iron accumulation.
Together these data will determine (1) if IL-1β signaling may serve as a trigger for retinal iron accumulation in
AMD and (2) whether IL-1β inhibition can be used to prevent iron accumulation in photoreceptors and RPE.
This grant will provide indispensable support towards my training as an aspiring scientist-ophthalmologist so
that I can achieve my ultimate goal of fusing clinical and basic science ophthalmology to create better
therapies for retinal disease.

Public health relevance
PROJECT NARRATIVE Despite decades of research implicating iron in the pathogenesis of age-related macular degeneration (AMD), the cause of this abnormal iron accumulation is not known. Recent work has linked chronic neuroinflammation to changes in iron homeostasis favoring intracellular iron accumulation. This proposal, to foster the development of an aspiring scientist-ophthalmologist, uses cell sorting in both human and mouse retina to elucidate the link between chronic inflammation of the retina and iron accumulation observed in the photoreceptors and RPE of patients with AMD.